CHEETAH Center for the Structural Biology of HIV Infection, Restriction, and Viral Dynamics

CORE SUMMARY
The ability to express, purify, characterize, and determine the structures of recombinant HIV-related proteins, RNAs, and
their complexes is central to the success of all of our Scientific Projects and Cores. Our Protein Production, Biophysical
Characterization, and Structure Determination Core (Core 3) is designed to ensure that all CHEETAH Center members and
trainees have access to state-of-the-art instrumentation and expertise in construct design, eukaryotic and bacterial protein
expression, biophysical characterization, X-ray crystallography, cryoEM, and training in biophysics and structural biology.
Services offered by Core 3 will build on our history of successes in expressing, characterizing, and determining the structures
of HIV-related proteins and complexes.
Component 1 (Expression and Purification of Proteins and Complexes) will support CHEETAH Center laboratories in the
production of proteins needed to gain mechanistic insight into processes important for HIV-1 biology, with potential to
inform the development of novel therapeutic approaches. All associated resources are located in the Department of
Biochemistry at the University of Utah.
Component 2 (Biophysical Characterization) will define and validate the biophysical properties of proteins and complexes
produced by CHEETAH Center members using state-of-the-art techniques and instrumentation. These data will provide
mechanistic insights, and will support and complement high-resolution structural studies. The associated instrumentation is
housed in the Department of Biochemistry at the University of Utah, and experimental design, implementation, and data
processing are conducted in collaboration with CHEETAH Center members. This Component will also perform a key
training role in our Visiting Scholars Program.
Component 3 (Structure Determination) will support CHEETAH Center laboratories by determining structures of proteins
and complexes that are important for HIV-1 biology. Structures will be determined by single particle cryoEM or X-ray
crystallography, thereby providing a foundation for mechanistic understanding with potential to inform the development of
novel therapeutic approaches. This Component will also perform a key training role in our Visiting Scholars Program.

Public health relevance
CORE NARRATIVE This Core will provide access to state-of-the-art instrumentation and expertise in construct design, protein expression, biophysical characterization, X-ray crystallography, cryoEM, and training in biophysics and structural biology.